Nanocage-based systemic delivery of TGFb trap for immunomodulation of brain neoplasms

Project Summary
Most of the patients with malignant brain cancer or glioblastoma (GBM) do not live more than 20 months despite
highly aggressive treatments, and those who do have a very high probability of tumor recurrence. State-of-the-
art therapeutic strategies that instruct and/or help our body's immune system to fight against malignant cancers
have been recently introduced and hope has been provided by success in clinical studies targeting non-brain
cancers. However, this so-called immunotherapy, particularly checkpoint inhibition, has failed to show
measurable benefits among patients with brain cancers in a number of recent clinical trials. This disappointing
reality is largely attributed to the unique ability of brain cancers to resist immunotherapy or to suppress our
defensive immune system. Specifically, transforming growth factor β (TGFβ) is highly upregulated and plays
pivotal roles in promoting the immunosuppressive tumor microenvironment in a multi-pronged manner in GBM.
Thus, we hypothesize that TGFβ blockade would mask the tumor immuno-suppression, thereby rescuing
checkpoint inhibition as a viable and potent treatment for GBM. Indeed, the validity and potential impacts of this
combined approach have been preclinically demonstrated in multiple non-brain malignant solid tumors. However,
its realization in GBM is yet to be accomplished due to inability to achieve uniform and robust delivery of TGFβ
inhibitors throughout the brain tumor tissue, including the particularly immunosuppressive hypoxic tumor areas.
The tightly sealed blood-brain barrier (BBB) precludes extravasation of systemically-administered therapy into
the brain tissue. Once beyond the BBB, therapy must percolate the highly dense and adhesive tumor
extracellular matrix to spread throughout the tumor tissue and reach hypoxic tumor regions distanced from blood
vessels. To this end, we propose to develop and evaluate innovative human ferritin protein nanocage-based
delivery platform capable of overcoming these challenging biological barriers for widespread TGFβ blockade
throughout the brain tumor tissue following systemic administration. We recently demonstrated that our prototype
nanocage provides stable systemic circulation, efficient extravasation and tumor uptake, tumor tissue penetration
as well as accumulation in hypoxic tumor regions. In addition, our pilot study shows that the nanocage specifically
designed to carry TGFβ trap provides markedly enhanced ability to block the immunosuppressive TGFβ signaling
in vitro compared to the clinically-relevant anti-TGFβ antibody. We also provide a proof-of-concept evidence
suggesting that this nanocage enhances therapeutic efficacy of a clinically used checkpoint inhibitor in a mouse
model of GBM. We thus expect that TGFβ-antagonizing nanocages to be further developed in this proposal will
dismantle the notoriously immunosuppressive nature of GBM and thus make the otherwise refractory immune
checkpoint inhibition highly efficacious in eradicating malignant tumor tissues from the brain. The proposed
approach, if successful, will provide a breakthrough in treating GBM and potentially other hard-to-cure cancers
as well.

Public health relevance
Project Narrative Unlike in other malignant solid tumors, state-of-the-art immune checkpoint inhibition has failed to provide therapeutic benefits in patients with glioblastoma to data primarily due to its notoriously immunosuppressive nature. Molecular TGFβ trap would counter the tumor immunosuppression and thus rescue the effectiveness of checkpoint inhibition, but a series of challenging biological barriers preclude widespread and uniform delivery of TGFβ trap to the brain tumor. We here propose to develop and evaluate human protein nanocage- based formulation capable of overcoming multiple delivery barriers, thereby providing efficient and uniform TGFβ blockade in brain tumors to ultimately enhance therapeutic efficacy of clinically-used checkpoint inhibitors.